Metadata Development, Curation, Harmonization and Program Support

 The purpose of this Statement of Work (SOW) is to supply specialized metadata development, curation, harmonization and program support on behalf of the National Institutes of Health (NIH), National Cancer Institute (NCI), Center for Biomedical Informatics and Information Technology (CBIIT) Metadata Content Development Team in its support of NCI IT and biomedical informatics coordination and management efforts.